Pathobiology of Liver Injury

PROJECT ABSTRACT. My long term career objective is to define the mechanisms of liver inflammation in
nonalcoholic steatohepatitis (NASH), the most-prevalent chronic liver disease in the United States of America.
NASH is characterized by endoplasmic reticulum (ER) stress, which results in release of proinflammatory
extracellular vesicles (EVs) from lipid overloaded (lipotoxic) hepatocytes. The contribution of recruited
monocyte-derived macrophages (MDMs) to the intrahepatic macrophage (IHM) pool increases in NASH and
the recruited MDMs play a pivotal role in inflammation. The current proposal examines the mechanistic link
between hepatocyte-derived EVs and specific MDM subsets. In preliminary studies we have identified that
activation of the lipotoxic ER stress activated endoribonuclease, inositol requiring enzyme 1 alpha (IRE1α) and
its target transcription factor X-box binding protein 1 (XBP1), upregulates the expression of S100A11. This
upregulation of S100A11 is associated with activating, histone 3 lysine 27, acetylation in the enhancer region
of S100A11. Lipotoxic hepatocytes release S100A11 containing EVs (S100A11-EVs). S100A11-EVs activate
macrophage receptor for advanced glycation endproducts (RAGE) signaling. Hepatocellular expression of
S100A11 and MDM expression of RAGE are upregulated in NASH. Silencing S100A11 decreases MDM-
associated hepatic inflammation in NASH. Based on these original preliminary data, we have formulated the
CENTRAL HYPOTHESIS that lipotoxic hepatocytes release S100A11-EVs which activate a subset of
proinflammatory RAGE expressing IHMs promoting NASH pathogenesis. Therefore, the goals of this
proposal are to understand: i) how S100A11-EVs are released by hepatocytes; ii) how RAGE is activated by
lipotoxic EVs in a subset of macrophages; and iii) can hepatic inflammation be attenuated by inhibiting
S100A11-EV-RAGE signaling? The proposed experiments will employ complementary in vitro and in vivo
models of lipotoxicity and NASH, and pharmacological, molecular and genetic approaches to address three
integrated hypotheses. First we will directly test the hypothesis that lipotoxic hepatocytes release S100A11-
EVs a) by XBP1 driven transcriptional upregulation of S100A11 by binding to and recruiting histone acetylating
factors to an enhancer region, and b) by selective cargo sorting of S100A11 into lipotoxic EVs. Second we will
directly test the hypothesis that RAGE is activated in a subset of macrophages by lipotoxic EVs a) by
generating multivalent signal competent RAGE oligomers, and b) leads to the accumulation of a subset of
proinflammatory RAGE expressing macrophages in the liver. Third we will directly test the hypothesis that
interrupting S100A11-EV induced RAGE activation attenuates murine NASH a) by reducing the release of
S100A11-EVs, and b) when macrophage RAGE is deleted. This R01 grant application will yield mechanistic
insights into hepatocyte-to-macrophage crosstalk in NASH, thus identifying potentially druggable targets, e.g.,
inhibitors of S100A11 or RAGE.

Public health relevance
PROJECT NARRATIVE This grant examines how liver cells damaged due to excess fat release small particles called extracellular vesicles which contain a danger signal called S100A11 to activate white blood cells termed macrophages, via a receptor called RAGE. These macrophages, in turn cause liver damage. This research is important because increasing obesity has resulted in large numbers of people with fatty liver disease, for which there are no proven treatments, and with these studies we aim to identify new potential treatments.